Role of the kappa opioid receptor system in learning and substance use disorders

Project Summary
Despite their high prevalence, the underlying neurobiology of substance use disorders is still not understood,
limiting effective pharmacological treatment options. Characterized by disruptions in learning processes,
substance use disorders are thought to develop with the transition from being motivated by the positive
reinforcing effects of the substance, to negative reinforcement where use occurs to avoid or alleviate an aversive
state during abstinence. It is hypothesized that substance-induced upregulations in kappa opioid receptor (KOR)
signaling play a causal role in the dysphoria that drives negative reinforcement. In support of this idea, KOR
antagonists decrease drug intake in models of chronic use or dependence and the nucleus accumbens, a region
critical to reinforcement learning and motivated behaviors, is one of the regions in which substance use has been
shown to upregulate the KOR system. Despite this evidence of a causal role for KOR signaling in substance use
disorders, this system’s function in adaptive reinforcement processes and the sufficiency of its upregulation in
driving maladaptive learning remains unknown. Here, we aim to address these issues through direct investigation
of the role of the KOR system in positive and negative reinforcement learning through pharmacological
manipulation, sub-second measurement of in vivo dynorphin dynamics, and optogenetic activation of the KOR
system. In aim 1, I will pair systemic antagonism of the KOR system with positive and negative reinforcement
operant conditioning tasks to elucidate the role of KOR signaling in adaptive learning. In aim 2, I will conduct
sub-second resolution, in vivo optical imaging of dynorphin release in the nucleus accumbens to uncover the
role of endogenous KOR system activity in encoding information during reinforcement learning processes.
Finally, in aim 3, I will optogenetically evoke accumbal dynorphin release to determine the sufficiency of
augmentation of the KOR system in driving the maladaptive learning that underlies addiction. Through the
completion of this proposal, I will receive well-rounded training in conducting independent research and
contribute to the field of addiction neuroscience’s understanding of the mechanism by which the KOR system is
involved in adaptive and maladaptive reinforcement learning processes.

Public health relevance
Project Narrative Substance use disorders are a major public health issue and are characterized by maladaptive learning processes resulting in overvaluation of drugs and drug-associated stimuli, as well as disruptions in non-drug reward reinforcement learning. Though upregulated kappa opioid receptor activity is thought to be implicated in maladaptive negative reinforcement processes underlying addiction, the role of both endogenous and augmented activity of the kappa opioid receptor system in learning has not been thoroughly investigated. The focus of this proposal is to directly assess predictions of this model by determining the endogenous role of kappa opioid receptor signaling in adaptive reinforcement learning and whether upregulation of the system is sufficient to drive maladaptive learning behaviors.